Quantitative Mechanoporation for High Throughput Cell Surgery

Abstract
Intracellular delivery of macromolecules into cells outside the body is an essential step in a wide range of
processes across biology, biotechnology, and medicine. Developing more flexible, scalable, and effective
delivery technologies is the central goal of Dr. Sevenler’s research group. Dr. Sevenler’s research is particularly
focused on understanding how the permeability of the plasma membrane to macromolecules can be momentarily
increased by applying a brief pulse of stretching force to the membrane, which is also called mechanoporation.
Although they and others have shown that mechanoporation can be highly effective for delivering molecules, the
specific mechanisms by which stretching leads to increased permeability are poorly understood. For example,
the number, size, distribution, lifetime, growth rate, and biomolecular composition of mechanopores have yet to
be resolved in living cells. These questions are clinically important, because macromolecule delivery is a critical
step in the production of many cell and gene therapies, and current delivery strategies are nonuniform, damaging
to cells, and/or not scalable to clinical production volumes. Over the next five years, Dr. Sevenler will
quantitatively measure when, where, and how mechanopores can be safely created in the membranes of human
cells outside the body and use this information to develop improved delivery strategies. To accomplish this, his
group will apply a range of experimental and numerical techniques in microfluidics, viscoelastic fluid mechanics,
biomaterials, and optical nano-imaging. Specifically, Dr. Sevenler’s research program will focus on two
interconnected areas of investigation to advance our understanding and applications of mechanoporation: (1)
quantitative characterization of mechanoporation; and (2) elucidation of membrane permeability and pore
structure. To investigate mechanoporation mechanics (1), Dr. Sevenler plans to develop and apply novel imaging
and microfluidic technologies to quantify cell deformation and membrane stress across relevant timescales. His
group is particularly interested in pulsed holographic imaging techniques and computational modeling of cell
mechanics in viscoelastic flows. To elucidate membrane permeability and pore structure over time (2), his group
will design and develop innovative analytical methods such as interferometric scattering microscopy and inertial
microfluidics-based permeability assays. Progress in these areas will contribute to developing safer, more
effective, and scalable intracellular delivery methods by collecting quantitative data about membrane disruption,
permeability, and repair in living cells. Our vision is to leverage this information towards a long-term goal of high
throughput cell “surgery,” wherein controlled amounts of macromolecules can be gently and efficiently delivered
into specific cellular compartments for therapeutic applications.

Public health relevance
Narrative The permeability of cell membranes can increase significantly when they are stretched, however the specific underlying mechanisms remains poorly understood. The objective of this work is to uncover how pores are created by stretching cell membranes, by characterizing the dynamic structure and permeability of these pores using new microfluidic and optical nano-imaging technologies. This knowledge will be valuable for developing better methods of delivering therapeutic genes, drugs, and nanoparticles into cells.